NRG Oncology Network Group Operations Center - BIQSFP Progress Report & Carryover GY10

Each BIQSFP has its corresponding justification attached to the BIQSFP's subaward budgets. Annual
Progress reports are attached to the “research strategy” section.

Public health relevance
Each BIQSFP has its corresponding justification attached to the BIQSFP's subaward budgets. Annual Progress reports are attached to the “research strategy” section.